Characterization and engineering of a compact genome editor for adeno-associated virus delivery to correct mutations causing cystic fibrosis

Project Summary/Abstract:
Cystic fibrosis (CF) is a monogenic disease caused by mutations in the cystic fibrosis transmembrane
regulator (CFTR) gene, which encodes for an important ion channel protein. While some mutations result in the
production of faulty CFTR protein, which can be modulated by small molecule therapies, rare nonsense
mutations prevent the production of CFTR and are currently untreatable. With the recent explosion in genome
editing technologies, such as CRISPR-Cas systems that can bind and cleave DNA with sequence specificity,
there has been increasing interest in correcting mutations in CFTR to provide a single dose, permanent genetic
cure for CF. However, current technologies for genome editing are larger than molecular delivery strategies can
handle, hindering the possibility of translating into a genetic cure for CF.
This study proposes the characterization and development of a compact genome editing tool that is
compatible with proven delivery vehicles for genome editing of CFTR mutations. CasΦ is a recently discovered
programmable endonuclease that is about half the size of other Cas nucleases and is functional in human
genome editing. In order to better understand how CasΦ behaves in human genome editing, mainly how CasΦ
recognizes intended DNA targets and discriminates from unintended DNA targets, high-throughput sequencing
screens in human cell culture will be employed. CasΦ will additionally be molecularly engineered into an adenine
base editor (CasΦ-ABE), a previously described set of tools that allows for sequence specific changes from A/T
to C/G without the creation of a double-stranded DNA break. CasΦ-ABE could correct nonsense point mutations
in CFTR, which are currently untreatable. Importantly, unlike current base editor technologies, CasΦ-ABE is
compact enough to be compatible with delivery methods such as adeno-associated virus (AAV), which has been
proven safe and effective in numerous clinical trials. At the conclusion of this study, CasΦ-ABE will be delivered
by a single AAV to primary human bronchial epithelial cells with nonsense mutations in CFTR, an important first
step toward developing a genetic therapy for CF.
The findings of this study will better characterize how CasΦ, a unique genome editing tool, works in
human cells. Additionally, this work includes the development of a CasΦ adenine base editor compatible with
delivery via AAV to correct nonsense mutations in CFTR. This study paves the way for a potential in vivo gene
editing therapy for CF. The University of California, Berkeley and the Innovative Genomics Institute offer a
collaborative, interdisciplinary, and world-class scientific environment that when complemented by the expertise
and resources of the Doudna Lab, will ensure the success of the proposed fellowship training plan.

Public health relevance
Project Narrative: Rare forms of cystic fibrosis, a disease that primarily causes life-threatening respiratory damage, are caused by nonsense genetic point mutations and are currently untreatable by small molecule therapies. The development of a compact genome editing technology that can safely and efficiently be delivered to the respiratory system may provide a permanent genetic cure for patients with these untreatable forms of cystic fibrosis.